COCAINE USE AND HIV ANTIRETROVIRAL THERAPY EFFICACY IN THE CNS

Project Summary/Abstract Human immunodeficiency virus-1 (HIV) enters the central nervous system (CNS) early after primary infection and results in a spectrum of cognitive deficits, collectively termed HIV associated neurocognitive disorders (HAND). While successful in reducing peripheral viral loads to undetectable levels, antiretroviral therapy (ART) does not effectively quell CNS viremia to the same extent. As a result, ART has not decreased the prevalence of HAND, which continues to increase as the life expectancy for seropositive individuals rises. HIV-infected substance abusers exhibit more severe cognitive impairment compared with their non-drug abusing counterparts. Specifically, cocaine use is associated with an accelerated incidence and progression of HAND. This occurs, in part, due to cocaine-mediated increases in HIV replication and resultant blood-brain barrier perturbations, alterations in ART metabolism, and neuroinflammatory responses that contribute to the sequelae characteristic of HAND. To understand more fully the impact of cocaine use on the pathogenesis of HAND, I will examine two major mechanisms by which cocaine may interfere with ART effectiveness in the CNS. I will evaluate the transport of ART across the blood-brain barrier in the context of cocaine, focusing on the expression and function of influx and efflux transporters. Additionally, I will characterize the association between polymorphisms in cytochrome P450 drug metabolizing enzymes and HAND in HIV-infected individuals who currently consume illicit substances, as well as those without current substance abuse.

Public health relevance
Project Narrative Human immunodeficiency virus-1 enters the central nervous system early after primary infection and results in a series of deficits ranging from minor cognitive impairment to frank dementia, collectively known as HIV associated neurocognitive disorders (HAND) that persist despite antiretroviral therapy. Cocaine, often abused by HIV-infected individuals, exacerbates the severity and/or disease progression of HAND, and shares common drug transport and metabolic pathways that may interfere with the effectiveness of antiretroviral therapy in the central nervous system. By examining the mechanisms by which cocaine alters the drug transport pathways that mediate antiretroviral influx and retention in the brain, this work may inform and guide dosing strategies for HIV infected drug abusers and also contribute to HIV eradication by limiting the brain as a viral reservoir.